Administrative Core

ABSTRACT:
The administrative core serves as the operational hub of the SPORE, arranging all SPORE related functions in
scientific review, intra- and inter-SPORE collaborations, financial management of budgeting and monitoring
expenses, editorial services as needed and grant administration. We also regard the SPORE as a forum for
education and mentoring, above and beyond what is directly assisted in the developmental programs, by
creating an environment in which new ideas for projects can be discussed with supportive SPORE key
personnel. The Core will coordinate the functions of the internal and external advisory boards and liaise with
the Memorial Sloan Kettering Cancer Center (MSKCC) breast cancer disease management team over
identification and monitoring of the cancer patient populations required for this SPORE and communicate with
our patient advocates about our ongoing results, trials and future planning.

Public health relevance
NARRATIVE: The administrative core is the integrative hub of all the activities described in the SPORE. It makes sure the projects, cores and developmental programs are functioning as planned. It will stimulate interactive science between the projects and collaborations with other SPOREs and programmatic research and with other investigators within MSKCC.